A chromatin structure informed exploration of gene regulation in Anopheles coluzzii

SUMMARY – In light of increased insecticide resistance, additional vector control tools are needed to slow
malaria transmission. A greater understanding of endogenous gene regulatory networks would greatly contribute
to evolutionary informed control strategies. The objective of this project is two-fold. First chromatin architecture
will be examined at coarse- and fine-grained scales in hemocyte cells with and without immune stimulation.
Second, we will dissect endogenous regulatory networks for immune deficiency (IMD) pathway genes and
develop an approach for detection of enhancer direct target genes rooted in enhancer RNA (eRNA) silencing.
The rationale is based on the observation that the dynamics of chromatin architecture are influenced by
underlying chromosome structure, including inversions, as well as by cell perturbations and differences in gene
regulation underlie many medically important phenotypes including the susceptibility to malaria parasites in
vector mosquitoes. Further, the ability to easily screen for enhancer target genes will be instrumental in our
understanding of endogenous gene regulation. Our two independent specific aims focus on understanding
endogenous gene regulation in hemocytes cells through examination of chromatin structure and dissection of
IMD regulatory networks; Aim 1) Map chromatin architecture during immune activation in mosquito hemocytes
and Aim 2) Identify gene regulatory networks for IMD pathway genes by modulating eRNA function. This project
is significant because little is known about endogenous gene regulation in mosquito hemocytes and prominent
methods of vector control, like genetically modified mosquitos, could be significantly strengthened and made
more evolutionary informed by a mechanistic understanding of gene regulation and gene regulatory networks.
The proposed project is innovative because it couples a high-resolution exploration of chromatin architecture
with modulation of eRNA levels for dissection of gene regulatory networks central to the IMD pathway. These
complementary, yet independent, ways to explore the function of non-coding regulatory elements will provide
new avenues for evolutionary informed vector control pertinent to the control of mosquito borne disease.

Public health relevance
Public Health Relevance Malaria remains a disease of public health importance and given the increased rates of insecticide resistance amongst mosquito vectors, more vector control tools are needed. The gene regulatory elements within the mosquito non-coding genome provide a largely unexplored avenue for evolutionary informed vector control strategies. Understanding chromatin architecture and gene regulation during immune challenge will significantly improve our understanding of biologically relevant mechanisms in this important vector of disease.